AI-Driven Digital Pathology Tool for Evaluating Inflammation and Therapeutic Efficacy in Preclinical Models

PROJECT SUMMARY/ABSTRACT
Inflammation is a biological response in many diseases and organ systems, including Graft-versus-Host Disease
(GvHD) and inflammatory bowel diseases (IBD). Toward alleviating the detrimental impact of acute or chronic
inflammation, there has been rapid development of cell therapies such as mesenchymal stem cells (MSCs).
While these have shown significant success in animal murine models for IBD and GvHD, dose efficacy and
mechanism of action remain open questions for research. Further, these therapies have seen mixed success
when evaluated in human patients, indicating a disconnect between preclinical and clinical evaluation of
therapeutic efficacy.
Experimental therapeutics in animal models are traditionally assessed on histopathology via pathologist scoring,
but this has been shown to suffer from subjective interpretation and variability. Correspondingly, the field of digital
pathology has had a transformative impact in biomedical research including significant advances in automated
and computational evaluation of digitized slides from human specimens. However, preclinical research has not
yet seen the benefits of rigorously developed digital pathology tools that are specifically optimized for slides and
data from animal models. More accurate quantification of the underlying aspects of inflammation in preclinical
data could help establish a more rigorous understanding of the therapeutic efficacy of cell therapies for
inflammatory conditions occurring across multiple organs and diseases.
Toward addressing these issues, this project will develop and validate a specialized suite of inflammation Digital
Pathology Tools (iDPT) which will comprise new pathomics and machine learning models tailored for use in
preclinical models of IBD and GvHD. iDPT modules will quantify domain- and data-specific characteristics of
disease and treatment effects, thus facilitating deeper mechanistic insights, accelerating the identification of
novel therapeutic targets, and ultimately contributing to the development of more effective treatments. This will
be accomplished via three Aims. Aim 1 will construct iDPT modules for pre-processing, annotation, and
quantitative assessment of inflammatory components on a pre-existing cohort of N=700 digitized hematoxylin
and eosin (H&E) slides from preclinical models of IBD and GvHD. iDPT modules will then be evaluated through
two distinct use-cases: (i) Aim 2 will evaluate the therapeutic efficacy of MSCs in a preclinical IBD model to
confirm dosing and cell viability for suppressing inflammation, and (ii) Aim 3 will evaluate the use of MSCs in
preventing the development of xenogeneic GvHD and mediating inflammatory response as a result of CAR-T
therapy. Our project is built on the principles of open access and multidisciplinary collaboration to ensure broad
impact for its outcomes, toward enabling innovation and discovery across the scientific community. Our long-
term objective is to establish a new paradigm for preclinical inflammatory disease studies, offering standardized,
scalable, and reproducible methods with broad impact while enabling discovery across the scientific community.

Public health relevance
PROJECT NARRATIVE This project will develop and validate a specialized suite of inflammation Digital Pathology Tools (iDPT) which will comprise new pathomics and machine learning models tailored for use in preclinical models of IBD and GVHD. iDPT will be validated for a deeper understanding of inflammatory response and therapeutic efficacy of novel cell therapies being developed for inflammatory bowel diseases (IBD) and Graft-versus-Host Disease (GvHD)